Thyroid Hormone Action in Alzheimer's Disease and Related Dementias

Abstract:
Thyroid hormone is among the most common prescriptions in the United States.
Up to 20% of those on therapy are on doses which suppress the normal pituitary
feedback system and result in a low thyrotropin (TSH) level, a sign of excess
hormone. We have recently found that a low TSH is associated with an increased
risk of a later diagnosis of cognitive disorder. This proposal aims to understand
whether excess thyroid hormone is a preventable risk factor for Alzheimer's
disease and related dementias. We will look at the relationship over time
between thyroid hormone therapy, hormone levels, and dementia in several
different large groups of patients. Our goals include identifying those who may be
particularly vulnerable to excess thyroid hormone. This work is important
because thyroid hormone is frequently prescribed to those with dementia and,
with millions of older adults at risk, even simple changes to appropriately
prescribe thyroid hormone could have important public health benefits.

Public health relevance
Narrative: Excess thyroid hormone has been associated with the development of Alzheimer's disease and related dementias (AD/ADRD). This project aims to clarify whether thyroid hormone is associated with the progression of AD/ADRD in a dose dependent manner and to determine what other characteristics make people particularly vulnerable to the actions of excess thyroid hormone for these outcomes. Since most excess thyroid hormone is the result of over treatment with thyroid hormone therapy, this work examines an important potentially preventable risk factor for AD/ADRD, a growing public health problem world- wide.